Magnetic Microrobots Assist AAV4 for CFTR Gene Delivery Through Mucus Barrier

Scientific Abstract
Cystic fibrosis (CF) is caused by mutations in the gene that encodes the CF
transmembrane conductance regulator (CFTR) anion channel. In CF patients, the loss of CFTR
impairs airway host defense mechanisms, leading to chronic airway infections and inflammation,
which are the primary causes of morbidity and mortality. It is generally believed that small
airways are involved early in the pathogenesis of CF lung disease. Understanding the
mechanisms underlying the pathogenesis is crucial for advancing CF therapy. Efficient and
targeted delivery of CFTR cDNA to the small airway epithelium could correct the CFTR defect,
restore host immune mechanisms, and prevent lung infections. Our research has demonstrated
that the AAV4 serotype can transduce both large and small airway epithelial cells. However,
delivering CFTR to small airways in CF animals and patients with advanced CF lung disease
poses a significant challenge due to mucus and airway obstruction, as the viscoelastic mucus
meshwork entraps and clears inhaled materials, efficiently removing them by mucociliary
escalation. Our recent work on micro/nanorobotics, an emerging technique for active and
targeted medicine delivery, indicated that microscale robots can be driven to penetrate
biological fluids and tissues. We hypothesize that image-guided, magnetically triggered
microrobots can facilitate AAV4-mediated CFTR gene delivery by penetrating the mucus
obstruction. To achieve this, we propose three specific aims: Aim 1: Develop a micro-robotic
AAV4 delivery system for CF airways. Aim 2: Test the hypothesis that the micro-robotic AAV4
delivery system-mediated transport of CFTR corrects airway surface liquid (ASL) properties and
restores Cl- and HCO3- transport in small airway epithelia in CF patients in vitro. Aim 3: Conduct
in vivo imaging and actuation of the micro-robotic AAV4 delivery system for CF treatment in a
CF mouse model. This project will lead to completely new concepts in the field of CF gene
therapy through direct mucus penetration and delivery. We built this project on the
interdisciplinary expertise in microrobot-based therapy (Jinxing Li Lab) and CF biology and
animal models (Xiaopeng Li Lab). If successful in our preclinical models, the new therapeutic
strategy can be translated and transform the therapeutic landscape of CF to benefit patients.
More broadly, the microrobot system can be further applied to other organs affected by CF,
such as the gut and pancreas, where mucus barriers exist.

Public health relevance
Project Narrative Cystic fibrosis (CF) is a prevalent genetic disorder caused by defects in the CFTR membrane pore protein, with lung disease as the leading cause of death among CF patients. This proposal aims to overcome the mucus barrier for correcting the CFTR defect by using microrobots for mucus-penetrating and AAV4-mediated CFTR gene delivery. This innovative therapeutic strategy has the potential to significantly alter the treatment landscape for CF, providing significant clinical advantages for patients.